Development of aerosol fluorescence spectrometer for measuring multiple physicochemical properties of respiratory and drug particles in situ

The key physicochemical properties of phase state, viscosity, and pH of aerosols and droplets impact both the
transmission of respiratory viruses and the efficacy of drug delivery to the lungs. Despite their critical role in
disease transmission and pulmonary drug delivery, a comprehensive understanding of these physicochemical
properties in fine and ultrafine aerosols is lacking. A major factor contributing to this knowledge gap is the
experimental challenge of measuring these properties in aerosols due to the small particle sizes and the
sensitivity of the particles to sampling, which can alter their properties. Current techniques used to study particle
physicochemical properties are generally limited to larger supermicron particles, require the perturbative
sampling of particles onto a substrate, and/or are only able to measure one relevant property. This proposal
seeks to bridge this knowledge gap by developing a single, fluorescence-based experimental apparatus capable
of in situ measurements of the phase state, viscosity, and pH of size-resolved fine and ultrafine respiratory and
drug aerosol particles. In Aim 1, we will develop the fluorescence apparatus and establish the basis for
measurement for each of these three properties. The incorporation of solvatochromic probe molecules will
enable the measurement of the phase state, molecular rotors will enable the measurement of viscosity, and pH-
indicators will enable the measurement of pH. Because the physicochemical properties of aerosols can vary with
particle size, we will integrate efficient size-selection with the fluorescence spectrometer to enable size-
dependent measurements in Aim 2. Standard electrical mobility-based methods for size-selecting fine and
ultrafine particles are hampered by distortions caused by larger multiply charged particles that share the same
electrical mobility as smaller singly charged particles. This proposal aims to overcome this limitation by combining
inertial impaction and electrical mobility to enable size-selection while retaining sufficient particle volumes for
fluorescence measurements. In Aim 3, we will develop techniques to incorporate probe molecules into pre-
existing aerosols to enable the eventual characterization of particles generated by individuals or preformulated
drugs. This aim will explore two distinct methods for achieving this incorporation: aerosolization of the probe
molecule itself, followed by controlled coagulation between probe-molecule particles and target particles, and
direct volatilization of probe molecules using semi-volatile probe molecules assisted by thermal or laser heating.
Taken together, the successful completion of these aims will provide proof of concept for a versatile measurement
platform capable of characterizing the key size-dependent physicochemical properties of fine and ultrafine
respiratory and drug aerosols. The capabilities of this new measurement platform will enable the elucidation of
the temperature- and relative humidity-dependent physicochemical properties of these particles. This
understanding has the potential to transform our ability to predict and control the spread of respiratory viruses
and enhance the precision and efficacy of drug therapies for respiratory and systemic diseases.

Public health relevance
Though the physicochemical properties of aerosols play a key role in respiratory virus transmission and in the effective delivery of drugs to the lungs, a comprehensive understanding of these properties has been hindered by the absence of high-quality in situ measurement techniques. This project aims to develop a fluorescence- based experimental apparatus capable of in situ measurements of the phase state, viscosity, and pH of size- resolved fine and ultrafine respiratory and drug aerosols. The eventual application of this instrument to characterize respiratory and drug aerosols will advance our ability to understand, predict, and control airborne virus transmission and pulmonary drug delivery.